Discovery and Development of Organic Reactions Catalyzed by Transition Metals Valuable for Medicinal Chemistry

Project Summary/Abstract
The NIH Diversity supplement will financially support the training and development of a first-
generation, Peruvian U.S. permanent resident Ph.D. candidate, who will be conducting research
in the topics disclosed in the parent grant. This student will be investigating the mechanistic
pathways of Cu-catalyzed C-N cross-couplings under a diverse set of dianionic ligand and
reaction conditions. Recent mechanistic findings showed that oxalamides, a type of dianionic
ligand, form a Cu(II) complex that catalyzes Ullman couplings of aryl halides with phenoxides by
a new mechanism involving redox “non-innocence” of the ligand. However, the generality of this
finding has yet to be established. The span of the ligands being surveyed differ by the degree of
conjugation in their backbone which is hypothesized to correlate with their likelihood of following
the mechanism involving ligand redox. Since Cu-catalyzed cross-coupling to form C-N bonds
occurs with copper complexes of several ligands that could also bind as dianions, testing these
systems will create a better understanding of the mechanisms of Cu catalyzed cross-coupling and
pave the way for more effective ligand design. In addition to these mechanistic and
methodological research plans, the candidate will follow an individualized development and
training plan we have created to best suit his career aims during his predoctoral training. These
activities will include participation and instruction in problem-solving sessions in synthesis and
catalysis, taking part in workshops to prepare the candidate for writing grants, working closely
with a postdoctoral mentor and the research advisor to prepare manuscripts and presentations,
as well enhancing his ability to present research results orally and to establish scientific networks
by attending and presenting at national conferences.

Public health relevance
Project Narrative To build a more diverse scientific community in synthetic chemistry and a fundamental understanding of reaction mechanisms, this diversity supplement will support the training and development of a Hispanic, U.S. permanent resident Ph.D. candidate who will be conducting research in the areas mentioned in the parent grant, with an emphasis on the development of improved synthetic methods for the creation of pharmaceutical candidates by the elucidation of the mechanistic pathways of widely practiced reactions that form aryl C-N bonds.